Mechanisms of Megamitochondria Formation in NASH

Despite being one of the most prevalent metabolic diseases in the United States, nonalcoholic steatohepatitis
(NASH) cannot currently be treated by any FDA-approved medicine. To develop effective drugs for this
disease, it is urgent and necessary to understand the pathogenic mechanisms of NASH. It has long been a
mystery why some NASH patients have extremely large mitochondria, termed megamitochondria, in their
hepatocytes. Our preliminary studies have revealed that megamitochondria is crucial factor for the NASH
pathogenesis and at least 20% of NASH patients possess megamitochondria in their hepatocytes. Therefore,
uncovering the mechanism of megamitochondria formation benefits in finding therapeutic targets for a large
portion of patients with NASH. Our study using a diet-induced preclinical NASH mouse model indicated
methionine- and choline-deficient (MCD) diet feeding developed megamitochondria in their hepatocytes.
Interestingly, however, choline-deficient (CD) diet feeding did not change mitochondrial morphology,
suggesting methionine deficiency is the key to megamitochondria formation. Previous studies have shown that
methionine is the dietary essential amino acid and its deficiency causes systemic metabolic changes in
multiple organs. Methionine is necessary for ribosomal docking and translational initiation because methionine
is the start codon. If this amino acid is insufficient, proteolysis is activated to obtain one from existing proteins
or polypeptides. Upregulated protein degradation releases a large number of free amino acids that will not be
used for protein translation. Because amino acids are primarily degraded in hepatic mitochondria via the TCA
cycle and the Urea cycle, excess amino acids are transported to hepatocytes. Given these findings, we
hypothesized that the elevation of systemic proteolysis would occur in the MCD diet-induced model, which
leads to the amino acid overload of hepatic mitochondria. When methionine deficiency occurs, the skeletal
muscles release a great deal of amino acids, due to the fact that 50-75% of our body's proteins exist in skeletal
muscles. And the activation of amino acid catabolism due to diet feeding would cause the megamitochondria
formation in this model. These hypotheses will be addressed in the experiments with the following Specific
Aims: 1) to determine whether skeletal muscle proteolysis is upregulated by methionine deficiency, and 2) to
determine the elevated hepatic amino acid catabolism drives the megamitochondria formation. If our
hypothesis is correct, it would suggest that the metabolic interaction between skeletal muscles and livers has
significant roles in the pathogenesis of megamitochondria-associated NASH. Moreover, it will demonstrate how
metabolic changes after amino acid overload affect mitochondrial morphology in hepatocytes. As a result of
these findings, new therapeutic strategies with novel targets will be developed to treat patients with NASH.